Mesothelin Vaccination for the Prevention of Ovarian CancerPOP: 09/15/2014-09/14/2016Preclinical Efficacy and Intermediate Endpoint BiomarkersHHSN261201200014I

This project will assess the potential cancer chemopreventive vaccine using mouse models.